Cognitive-based Rehabilitation Platform of Hand Grasp after Spinal Cord Injury using Virtual Reality and Instrumented Wearables

PROJECT SUMMARY
Spinal cord injury (SCI) at the cervical level impairs hand function and the ability to engage the environment. As
a result, the ability to perform activities of daily living can be severely compromised, directly leading to reduced
quality of life. Physical therapy is still the primary pathway to restore functional abilities after SCI. The physical
rehabilitation process requires commitment by the participant to achieve meaningful gains in function.
Rehabilitation approaches that are cognitively engaging can facilitate greater commitment to practice and
improved movement learning. We propose to develop innovative platforms that utilize virtual reality (VR) and
instrumented wearables that enhance cognitive factors during motor learning of hand grasp and reach after SCI.
These factors include greater sense of agency, or perception of control, and multi-sensory feedback. Sense
of agency is implicated with greater movement control, and various sensory feedback modalities (visual, audio,
and haptic) are proven effective in movement training. However, these factors are not well considered in
traditional physical therapy approaches. We have developed two novel cognitive-based platforms for
rehabilitating grasp and reach function. We propose to test each platform in Veterans with chronic SCI at the
cervical level. In Aim 1, we will investigate how our first platform, the “cognition” glove, may improve functional
grasp. This glove includes force and flex sensors that provide inputs to a machine learning algorithm trained to
predict when secure grasp is achieved. The glove alerts the user of secure grasp through onboard sensory
modules providing visual (LED), audio (beeper), and tactile (vibrator) feedback. During training, feedback is
provided at gradually shorter time-intervals to progressively induce agency based on the neuroscience principle
of ‘intentional binding’. This principle suggests that with greater agency, one perceives their action (i.e., secure
grasp) is more coupled in time to a sensory consequence (i.e., glove feedback). Our glove is user-ready, and
now has compatibility with customized VR applications to provide enhanced sensory feedback through engaging
and customized visual and sound alerts. We hypothesize that enhanced feedback in VR will produce even
greater improvements in grasp performance than onboard feedback alone. In Aim 2, we investigate how
Veterans with SCI may learn greater arm muscle control during virtual reaching. We have developed a “sensory”
brace that provides isometric resistance to one arm to elicit electromyography (EMG) patterns that can drive a
virtual arm. The person receives visual feedback from VR and muscle tendon haptic feedback from the brace
during training. Tendon stimulation can elicit movement sensations that modulate muscle activation patterns.
The VR feedback will provide conscious movement training cues while vibration feedback will subconsciously
elicit more distinct EMG patterns based on cluster analysis. We hypothesize that the promotion of distinct EMG
patterns, achieved by maximizing inter-cluster distances, will improve performance of a reach-to-touch task.
Performance of both the grasp and reach task in each Aim is assessed according to metrics that describe the
timing, efficiency, and accuracy of movement. For a future MERIT proposal, we intend to integrate these
platforms to train better operation of powered assistive devices, including a hybrid (motor power and functional
electrical stimulation of muscle) exoskeleton of the hand. Importantly, the concept of strengthening cognitive
agency and learning of movement using wearable technology, multi-sensory feedback, and virtual reality during
physical training will be applicable to all forms of neuromuscular impairment, including stroke and traumatic brain
injury in addition to SCI. Our team is ideally positioned to take the next steps in developing, translating, and
applying this technological approach, which matches the Rehabilitation Research and Development Service’s
goals.

Public health relevance
Rehabilitation of functional movements after spinal cord injury (SCI) requires commitment and engagement to the processes of physical therapy. Outcomes may be improved by techniques that strengthen cognitive connections between users and physical therapy exercises. We will investigate combinations of virtual reality and innovative wearable technology to accelerate rehabilitation of hand grasp and reach. These devices use multi-sensory feedback to enhance the sense of agency, or feelings of control, and better train movements during physical rehabilitation exercises. We will measure the effect of these devices on improving the speed, efficiency, and accuracy of performed movements in Veterans with SCI.